Characterize the metabolic landscape of ARID1A-mutated ovarian cancer

Abstract
Ovarian clear cell carcinoma (OCCC) is a rare and highly lethal gynecological cancer. The majority of
OCCC patients carry inactivating mutations in ARID1A, a component of the SWI/SNF chromatin-
remodeling complex, leading to a lack of response to standard chemotherapy and poor prognosis. To
address this unmet medical need, recent research, including from our own laboratory, has suggested
that targeting mitochondrial respiration may be a promising approach for treating ARID1A-mutated
tumors. However, there is still a significant knowledge gap in understanding the specific mitochondrial
Electron Transport Chain (mETC) components that contribute to the dependency of ARID1A-deficient
cancer cells on mitochondrial respiration. Current mitochondrial inhibitors lack specificity and often
cause severe side effects. This grant proposal aims to identify unique proteomic and functional
mitochondrial signatures associated with ARID1A deficiency in OCCC tumors. Additionally, it seeks
to perform a genetic screen of mETC drop-out in ARID1A-proficient and deficient cells. The results
from this research could reveal potential therapeutic vulnerabilities within the mETC for ARID1A-
deficient tumors, not only in OCCC but also in other cancers with ARID1A mutations. The innovative
aspect of this grant lies in conducting a comprehensive analysis of mETC in ARID1A wild-type and
mutated tumors and performing the first-ever mETC genetic screen in ARID1A-proficient and deficient
cells. The findings from this research have the potential to uncover novel therapeutic targets for
ARID1A-deficient OCCC tumors and may have broader implications for unresponsive tumors in
different contexts.

Public health relevance
Project Narrative Ovarian clear cell carcinoma (OCCC) is the deadliest of the gynecological cancers and is characterized by ARID1A mutations. Rigorous evidence (including from our laboratory) shows that ARID1A-deficient cancer cells increase their mitochondrial respiration. This grant aims to determine the specific functional mitochondria signatures associated with ARID1A loss and to identify new therapeutic vulnerabilities for ARID1A-mutated tumors to improve outcomes for women diagnosed with this disease.